Cellular and molecular analysis of B lymphocyte development and selection

The bone marrow (BM) produces myeloid and lymphoid cells at a rate that ensures hematopoietic cell
homeostasis. How hematopoietic cell production is regulated to control the size of the peripheral hematopoietic
cell compartment is not understood. During systemic infection and/or inflammation, lymphoid production is
halted while myelopoiesis is increased, a process that is known as emergency myelopoiesis. How systemic
inflammatory signals alter the BM microenvironment to enable dramatic and quick hematopoietic shifts is also
largely unknown. We propose to address these fundamental questions by studying B cell development under
homeostasis and during systemic inflammation. Studies over the past 6 years identified Leptin receptor-
expressing mesenchymal progenitor cells (Lepr+ MPCs) as the major cells producing SCF, IL-7, and the
chemokine CXCL12, that are critical for hematopoietic stem cell maintenance and hematopoietic precursor
commitment into the lymphoid lineage. This type of niche organization suggests that cross-talk between
hematopoietic cells and Lepr+ MPCs occurs in vivo, but so far no specific signals delivered by hematopoietic
cells to Lepr+ MPCs have been identified. In this grant we provide evidence showing that Lepr+ MPCs express
Lymphotoxin beta receptor (LTbR) and that LTbR signaling downregulates IL-7 production. Mature B cells that
naturally recirculate through BM express the LTbR ligand LTa1b2. Furthermore, while normal B cell
progenitors express little LTa1b2, pre-leukemic preB cells significantly up-regulate LTa1b2 and reduce IL-7
produced by Lepr+ MPCs in vivo. In aim 1 we will test the hypothesis that LTbR signaling in Lepr+ MPCs
regulates the quality and size of the B cell compartment. Our preliminary findings also revealed that Lepr+
MPCs significantly reduce IL-7 expression during systemic inflammation in a LTbR-dependent manner.
Importantly, when Lepr+ MPCs cannot shut-down IL-7 production, B lymphocytes continue to be made, and
myeloid cell production is significantly reduced. Remarkably, survival against a high dose of Listeria
monocytogenes infection is critically dependent on LTbR signaling. Through experiments described in Aim 2
we will test the hypothesis that LTbR signaling in Lepr+ MPCs is the major molecular pathway controlling
emergency myelopoiesis. Finally, as CXCL12 production is quickly reduced during systemic inflammation,
most hematopoietic cells are rapidly mobilized from BM into the periphery, with the notable exception of mature
B cells that double in number in BM in the early hours after inflammation. In Aim 3, we will test the hypothesis
that mature B cells play a novel and unsuspected role in innate immunity through BM homing and interaction
with Lepr+ MPCs for delivery of “instructive” LTbR signaling in these cells. We also propose to study the
mechanism(s) used by mature B cells to home and be temporarily retained in BM during systemic
inflammation. The proposed aims will provide a broad conceptual and mechanistic framework for
understanding how bone marrow stromal cells influence cell lineage decisions.

Public health relevance
Defects in B cell development are major causes of immunological diseases. By investigating where and how B cells migrate and position within bone marrow we may develop new therapeutic strategies against devastating immunodeficiencies, malignancies, and autoimmune diseases.